Extracellular RNAs: Biomarkers for Cardiovascular Risk and Disease

DESCRIPTION (provided by applicant): Cardiovascular disease (CVD) and stroke are two of the leading causes of morbidity and mortality among adults in North America and are strongly determined by levels of common CVD risk factors including hypertension, diabetes, obesity, cigarette smoking, and dyslipidemia. Specific extracellular RNAs regulate key processes central to the pathogenesis of CVD and several small human studies have associated extracellular RNAs with specific forms of CVD. We postulate that the expression of plasma RNAs change over time and is influenced by the duration and intensity of exposure to CVD risk factors, relates to subclinical atherosclerosis phenotypes, and will therefore be useful predictors of incident CVD events. We intend to further explore and validate the diagnostic and prognostic utility of extracellular RNAs associated with CVD and preclinical CVD phenotypes in our community-based cohort study in a hospitalized sample with acute coronary syndromes. To accomplish these aims, in the U2 phase of our study we will use an optimized non-commercial isolation method for high-yield plasma RNA extraction as well as high-throughput sequencing to identify known and as-yet undiscovered extracellular circulating RNAs, thereby developing a broad panel of plasma-derived extracellular RNA biomarkers (including miRNA, piRNA, noncoding RNAs) to screen 2914 participants in the Framingham Heart Study (FHS) Study (Offspring Exam 8). In the U3 phase of the application, we will further evaluate changes in circulating RNAs over time and in relation to incident CVD and disease progression, by screening the same individuals 5 years later (Offspring Exam 9). We will then examine associations between extracellular RNAs and CVD-related prognosis in ~400 participants of TRACE-CORE (Transitions and Research in Acute Coronary Events - Center for Outcomes Research and Education). We will perform exploratory analyses to determine if these methods can be extended to non-CVD populations. Last, we will partner with industry leaders to develop a quick and effective point-of-care test for extracellular RNA profiles associated with disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Specific RNAs found in the circulation outside of cells may regulate key processes that influence the development of disease and/or be markers of its presence or progression. Cardiovascular disease is a leading cause of morbidity and mortality among adults in North America. Using currently available plasma samples from several well-characterized observational and patients populations extending beyond cardiac syndromes, these two projects aim to define the expression of circulating RNAs in health and disease. __SpecificAimsTextDelimiter__ Cardiovascular disease (CVD) and stroke are two of the leading causes of morbidity and mortality among U.S. adults and are strongly determined by CVD risk factors including hypertension, diabetes, obesity, smoking, and dyslipidemia. Specific extracellular RNAs regulate key processes central to the pathogenesis of CVD. Several small human studies have associated extracellular RNAs (exRNA) with CVD and several of its risk factors. We postulate that circulating plasma levels of exRNAs i) vary over time even in disease-free individuals, ii) are associated with the duration and burden of CVD risk factors, iii) relate to subclinical atherosclerosis, and iv) are useful predictors of longitudinal changes in CVD risk factors and incident CVD events. Using a community-based cohort study, we propose to further examine and validate the diagnostic and prognostic utility of exRNAs associated with CVD and preclinical CVD phenotypes in the community and in a hospitalized acute coronary syndrome sample. In the UH2 phase of our study we will use an optimized non- commercial isolation method for high-yield plasma RNA extraction developed by Dr. Ambros and his team. We will conduct high-throughput sequencing to identify known and as-yet undiscovered circulating exRNAs, thereby developing a broad panel of plasma-derived exRNA biomarkers (including miRNA, piRNA, noncoding RNAs) via screening of Framingham Heart Study (FHS) participants. In the UH3 phase, we will further evaluate changes in circulating exRNAs over time and in relation to incident CVD and disease progression, by screening the same individuals 5 years later. We will then examine associations between exRNAs, CVD, and CVD-related prognosis in 400 participants of TRACE-CORE (Transitions and Research in Acute Coronary Events - Center for Outcomes Research and Education). Lastly, we will partner with industry leaders to develop a quick and effective point-of-care test for exRNA profiles associated with CVD. The Specific Aims of the UH2 proposal will identify and develop exRNA-based biomarkers: Aim 1. Isolate exRNA from human blood plasma samples using advanced fractionation methods (endosomes, proteins, lipids) and develop methods optimized for high-throughput and robotic handling so as to transition to clinical populations. Aim 2. Perform high-throughput RNA sequencing (RNA-seq) on previously stored plasma from FHS participants (Offspring Exam 8) including those with/without CVD so as to identify an initial working panel of ~588 plasma-expressed exRNA sequences, consisting of all those that appear to distinguish disease from disease-free states, as well as a set of invariant normalization controls. Aim 3. Use high throughput qRT-PCR assays to validate and refine the initial working panel of candidate exRNA biomarkers identified by RNA-seq in Aim 2. In this Aim, exRNA levels (~588) will be quantified in samples of stored plasma from 2914 participants of the FHS Offspring Cohort (8th visit). Data from these qRT-PCR profiles will be analyzed with other clinical data (risk factors, and contemporaneously measured mRNA/protein expression) previously obtained and available for all participants. Aim 4. Using data from Aim 3, begin development of target-specific probes attached to Firefly hydrogel particles and determine the feasibility of measuring specific panels of exRNA in clinical samples. The Specific Aims of the UH3 proposal will validate plasma extracellular RNA longitudinally and quantify its expression in other diseased populations: Aim 5. Longitudinal exRNA expression will be determined using RNA-seq and plasma from select participants (per Aim 2) from the FHS Offspring cohort during their 9th Exam, representing 5-year follow-up. Aim 6. Using the biomarkers identified in Aim 5, exRNAs from stored plasma will be measured (using qRT- PCR) in the entire FHS Offspring Exam 9 cohort. In addition, these exRNAs will be measured from the minority FHS Omni cohort (~298) from their 3rd and 4th visits using previously stored plasma. Expression changes over time will enable discovery of diagnostic biomarkers of CVD risk factors (e.g. progression from prehypertension to hypertension, elevated fasting glucose to diabetes) and CVD risk. Aim 7. Broaden and contrast the findings from Aims 5 and 6 using plasma samples from 400 patients hospitalized with acute coronary syndromes enrolled in TRACE-CORE. Aim 8. Extend and commercialize methods established in Aims 1-7 to non-CVD clinical populations. Throughout the UH2 and UH3 proposals, these studies will use state-of-the art extraction techniques, new technologies, and well-defined observational and patient populations to identify the exRNAs of potential utility as disease risk markers. The multidisciplinary team of investigators are uniquely qualified to conduct the proposed studies; Dr. Ambros discovered miRNAs and continues to pioneer avenues for extracellular miRNA isolation and extraction; Dr. Levy has vast understanding of the FHS and its data resources and has led the overall SABRe CVD Initiative; Dr. Freedman's laboratory has extensive experience in performing high- throughput miRNA measurements in large clinical and epidemiological samples, including the FHS. Importantly, a communication, performance, and formal sharing plan will be put in place and all data obtained in this proposal will be shared with other RFA members and be deposited into public databases.